Cellular plasticity and regeneration afterradiation damage in Drosophila

Cellular plasticity and regeneration after radiation damage in Drosophila
Cellular plasticity and regeneration after radiation damage in Drosophila
More than half of cancer patients receive ionizing radiation (IR), alone or as a component of their
treatment (www.cancer.org). IR induces DNA damage to kill cells. Surviving cancer cells could, however,
regenerate the tumor, leading to treatment failure. While we understand much about how irradiated cells repair
damaged DNA or undergo cell death, how tumors regenerate remains incompletely understood.
The overall objective of our research program is to understand how tissues regenerate after damage by
IR in vivo in a multicellular context, to identify and characterize the genes and proteins involved in this process,
and to develop genetic and chemical tools to manipulate the function of these regulators. Drosophila
melanogaster has been an ideal organism for this work because of precision lineage tracing tools, amenability
to genetic and chemical screens, and the ease of molecular analysis to uncover gene function. Cell death and
regeneration in Drosophila and vertebrates share conserved genetic and molecular features. Chemical
modulators of IR-induced regeneration we discovered in Drosophila behave similarly in human cancer models.
Therefore, what we learn in Drosophila is likely to apply to humans.
Regeneration of Drosophila larval organs called imaginal discs occurs without a dedicated stem cell
pool. My lab identified a previously unknown mode of regeneration in Drosophila larval wing discs whereby a
specific subset of columnar epithelial cells in the future hinge region change fate to acquire stem cell-like
properties. IR-induced cell fate plasticity in Drosophila parallels the increasingly appreciated ability of cancer
treatments including IR to induce stem cell-like properties in non-stem cancer cells, a phenomenon implicated
in tumor re-growth and treatment failure. Progress in the current funding period includes the finding that IR-
induced fate change requires ribosome biogenesis and apoptotic caspase activity in hinge cells that are
nonetheless refractory to IR-induced apoptosis. These findings lead to a conceptually innovative working
model in which changes in the proteome through non-lethal caspase activity and increased translation capacity
act on top of changes to the transcriptome to affect cell fate change. Rigorous testing of this model will guide
our future activities that will include asking why cells change fate into one cell type but not another. Technical
innovation is inherent in quantitative assays for IR-induced cell fate plasticity. The ultimate goal is a
comprehensive understanding of how changes in the translated transcriptome are coordinated to promote IR-
induced cell fate plasticity in the context of organism development. What we learn will not only increase our
understanding of regeneration after IR damage but also will identify mechanisms that may be modulated to
improve treatment outcome in human cancers.

Public health relevance
NARRATIVE Radiation therapy of cancers fails when surviving cells repopulate and regenerate a tumor. Our goal is to identify and study genes and proteins needed for such regeneration. Inhibition of these genes and proteins, with drugs for example, could prevent regeneration and thereby increase the potency of radiation therapy.